Penn Mental Health AIDS Research Center

Project Summary/Abstract
People
incidence
who inject drugs (PWID) are disproportionately affected by HIV incidence in Philadelphia. The HIV
in Philadelphia is growing and returning to pre-COVID pandemic levels.At present, the city health
department's Department of HIV Health funds many community and clinical health providers for HIV testing and
counseling services, including HIV Service Organizations (HSOs), substance use treatment centers, and
emergency departments, which have facilitated the detection of many new cases among PWID in Philadelphia.
Despite these successes, increasing infection rates in PWID suggest a need for scaled-up detection and linkage
strategies. Reliance on traditional HIV prevention providers may yield missed opportunities for HIV diagnoses,
timely linkage-to-care, and cluster detection and response. Leveraging providers in healthcare and social service
environments outside of traditional HIV prevention settings in neighborhoods with high rates of IDU may
maximize opportunities for expanding efforts for HIV cluster detection and response. The extent to which
nonclinical HSO-alternative service providers in these areas understand IDU as a significant contributor to the
HIV epidemic, routinely conduct or refer PWID high-quality HIV testing services, and are willing and capable to
integrate or scale-up HIV testing services within current clinical operations at their agency is poorly understood.
To address these gaps, we propose a 2-year study to conduct the following aims: (Aim 1) Employ persons with
lived experiences/histories of IDU to conduct secret shopper methodologies toward understanding the current
HIV testing/referral practices in nonclinical HSO-alternative outpatient service facilities (N = 15) in Philadelphia
neighborhoods with high IDU; (Aim 2) Deploy surveys with N = 100 PWID living without HIV to evaluate
environmental preferences for HIV prevention services in nonclinical HSO-alternative outpatient service facilities
in Philadelphia; and (Aim 3) Engage with representatives from secret shopper-evaluated facilities through
stakeholder meetings to discuss secret shopper feedback, their perceptions of the HIV epidemic among PWID
in their service area, and their capacity for HIV prevention services. The proposed study will facilitate local
priorities pertaining to the Diagnose pillar of the Ending the HIV Epidemic Initiative and support the city health
department's HIV cluster detection and response strategies. Leveraging HSO-alternative providers' capacities
to conduct, refer, and coordinate HIV testing will maximize equitable access to HIV prevention for PWID and
opportunities to identify new HIV cases and unidentified clusters missed via traditional HIV testing environments,
like HSOs.

Public health relevance
NARRATIVE Effective HIV cluster detection and response strategies must leverage community partnerships with nonclinical community-based organizations in geographic regions where high HIV incidence is attributed to injection drug use. Community-based organizations outside of traditional HIV Service Organizations may facilitate the identification of existing HIV cases and support status-neutral linkage to care. The purpose of this proposal is to leverage secret shopper evaluations, service environment acceptability surveys with people who inject drugs, and stakeholder meetings with secret shopper-evaluated sites toward the development of HIV testing partnerships that support the Philadelphia Department of Public Health Division of HIV Health's cluster and detection response activities